Next-generation Upgrade for 7T Human MRI System

PROJECT SUMMARY/ABSTRACT
This application seeks support from the ORIP High-End Instrumentation (HEI) Grant program to fund the latest
generation Siemens 7 Tesla (7T) whole-body human MRI system to be used for basic/clinical/translational re-
search at the Athinoula A. Martinos Center for Biomedical Imaging at the Massachusetts General Hospital. This
system will replace our existing 22-year-old prototype 7T human MRI scanner, which was the second in the world
and the first with a clinical console. While this prototype 7T system supported the Martinos Center’s ultra-high
field research program for over two decades, the 7T magnet is no longer serviceable by the manufacturer (Agilent)
and the scanner is no longer supported for future upgrades by the manufacturer (Siemens). Therefore, usage
of this system is winding down as the final projects are completed, and we plan to gracefully retire this historic
7T system in 2024. The new system – a Siemens Terra.X whole-body 7T scanner – will provide a substantial
increase in performance for the wide range of NIH-funded research at the Martinos Center and the greater Boston
area community, including clinical and neuroradiological studies of the central nervous system (brain and spinal
cord), as well as imaging of the throat, knee, and skeletal muscle; cognitive, psychiatric, and basic neuroscience
and brain mapping studies; multinuclear spectroscopy; and novel instrumentation development.
The features and benefits provided by the Siemens Terra.X include: streamlined and standardized workflows
for greater ease of use, enabling a broader user base as well as robustness and consistency across sessions;
standardized hardware and software for compatibility with other sites, enabling new, collaborative large-scale
multi-site trials; improved manufacturer support and maintenance for a product system moving forward, reduc-
ing the burden currently placed on Martinos Center staff; enhanced system performance including 16 parallel
transmit channels and 64 radiofrequency (RF) receive channels, stronger and faster gradient coils, higher-order
magnetic field shims, increased RF power, a faster image reconstruction computer, high temporal resolution phys-
iological monitoring, and new sequence and application packages compatible with the newly released Siemens
platform; and an up-to-date testbed for the unique instrumentation and technology research and development
performed at the Martinos Center, including advanced imaging sequences and reconstruction, higher-density
receive coil arrays, and shim-RF multi-coil arrays to be both shared with our industrial collaborators and freely
disseminated to the MRI community. Additionally, this scanner will operate in either “MR only” mode or – after the
insertion of a next-generation removable, custom-designed positron emission tomography (PET) camera (funded
by U01EB029826) – as a novel 7T PET/MR system with an order of magnitude improvement in PET sensitivity.
Therefore, this unique Next-generation Upgrade for 7T Human MRI System is poised to support the next two
decades of innovative 7T research at the Martinos Center by dissolving the barriers between 7T and PET, thus
serving both the ultra-high field MRI and PET imaging communities.

Public health relevance
PROJECT NARRATIVE This application supports the purchase of a next-generation 7 Tesla whole-body human MRI scanner at the Athinoula A. Martinos Center for Biomedical Imaging to replace our 22-year-old prototype 7 Tesla scanner that will soon be decommissioned. The new instrument – a Siemens Terra.X 7 Tesla scanner – will support at least 20 NIH-funded investigators at the Martinos Center and the greater Boston area community. This whole-body MRI scanner is designed to function with a next-generation removable positron emission tomography (PET) camera with an order of magnitude improvement in PET sensitivity, thereby serving both the ultra-high field MRI and PET imaging communities.